Expanding the pool of Independent Investigators in Implementation Science in Nigeria throug h HIV research training (EXPAND)

PROJECT SUMMARY
The research proposal on facility-based screening for Hypertension and Associated
Non-communicable Diseases in young adults living with HIV/AIDS (HANDY) speaks to the
aims of the parent training grant EXPAND (D43TW012280), whose goal is to establish long-term
structured hard and soft skills training and mentoring to guide early-career Nigerian researchers
for independent investigator-ship and research leadership at the International Research Center
of Excellence at the Institute of Human Virology Nigeria (IRCE-IHVN). Dr. Ahmad Aliyu, a former
Fogarty trainee who currently serves as the Senior Technical Advisor (STA) for Monitoring and
Evaluation (M&E) at IHVN will lead the execution of this supplement. In addition to support from
the MPIs with relevant expertise in studying adolescents with HIV (Dr. Sam Agudu) and HIV
exposed uninfected persons (Dr. Abimiku); Dr. Aliyu will be mentored by two additional faculty;
Dr. Dakum at IHVN and Dr. Stafford at University of Maryland School of Medicine (UMSOM), both
Associate Professors of Epidemiology and Public Health at UMSOM with expertise in HIV and
aging. The proposed supplement will address critical gaps in our understanding of the impact of
comorbidities such as non-communicable diseases (NCDs) on general health and aging among
Adolescents And Young Adults Living with HIV (AYALWH).
Access to durable and tolerable antiretroviral therapy (ART) has transformed HIV into a
chronic condition and has dramatically increased life expectancy.1 Today a young person with
HIV and on ART can expect an overall lifespan similar to the general population; however, they
are likely to have a shorter comorbidity-free life expectancy than young people without HIV.
Approximately 12% of the 1.9 million people living with HIV in Nigeria are adolescents (UNICEF,
2019) and annual HIV incidence is highest among adolescents and young adults ages 15-34
years.2 There is overwhelming evidence from the literature that demonstrates accelerated
biological aging due to HIV infection and associated clinical manifestations among perinatally-
infected person with HIV (PHIV) and PLWH in general.3 Indeed, a characteristic phenotype of
NCDs is accelerated aging from DNA damage, telomere shortening and irreversible oxidative
damage.4 Additional evidence also shows that HIV infection and use of ART potentiate early onset
of geriatric syndrome and recommends early screening and further studies on comorbidities with
non-communicable diseases (NCD) among PLWH on ART.5,6 Studies on HIV and aging are
scanty in Nigeria and even less in adolescents and young adults. Available studies also
recommend further studies on NCDs among PLWH on ART. HANDY will be conducted within the
context of Presidents’ Emergency Plan for AIDS Relief (PEPFAR) program implementation by
IHVN, and would address a priority area in the National Multi-sectoral Action Plan (NMSAP) for
the Prevention and Control of NCDs 2019-2025. HANDY will focus on these two specific aims:
1. To determine the prevalence of hypertension and associated metabolic disorders
among PHIV compared to HIV-exposed and uninfected (HEU) and HIV-unexposed and
uninfected (HUU) young adults.
2. To improve early detection of hypertension and associated metabolic disorders among
AYALWH, and linkage to care for appropriate management and care
Using a cross-sectional study design, HANDY will recruit 450 participants from three groups: 150
PHIV, 150 HEU and 150 HUU young adults aged 18-24 years. The source population of potential
study participants are engaged in care PEPFAR-supported Operation triple zero (OTZ) sites in
Federal Capital Territory (FCT) and Nassarawa supported by IHVN, where 7,127 eligible
individuals are currently receiving care. (Refer to Table 1). Data will be collected on history of
prior HIV exposure in-utero, HIV sero-status, antiretroviral therapy (ART) status, anthropometry,
BP measurement, and screening for metabolic disorders. HANDY achieves the following 1) early
detection of HTN and associated metabolic disorders 2) referral for specialized care and
management to prevent complications to prevent early and late of sequelae 3) reducing morbidity
and mortality among those with associated NCDs.
The project reduces the burden of NCDs and increases access to care and treatment

Public health relevance
1. PROJECT NARRATIVE 1.1. EXPAND (D43TW012280), the parent grant tied to this supplement was recently funded through the world-class International Research Center of Excellence at Institute of Human Virology – Nigeria (IRCE-IHVN), to establish a structured training and mentoring program to support early Nigerian researchers for independent investigator-ship and research leadership. The proposal supports addressing the capacity gap as identified from needs assessments by the Nigerian National HIV/AIDS Research Reference Group, National Agency for the Control of AIDS as well as Fogarty International Center (FIC), and NIH’s Strategic Plans for global health and for HIV. It also addresses a priority research area to improve understanding of the impact of aging on PLWH across the lifespan. Using a prior capacity building and mentoring strategy “mentor-the-mentor” supported by FIC, US faculty expert and a Nigerian counterpart would jointly act as co-mentors to Dr. Aliyu to undertake research on HIV and aging. In this supplemental submission to EXPAND, Drs. Kristen Stafford and Patrick Dakum, both Associate Professors of Epidemiology and Public Health and with research expertise and publications on aging and NCDs. Dr. Stafford’s work recently described the prevalence of HTN among perinatally-infected young adults and those recently infected and HUU in Baltimore. Dr. Dakum also led a meta-analysis and of global citations on HTN among older PLWH. Both would oversee and guide the research project proposed by Dr. Ahmad Aliyu, a former Fogarty trainee. 1.2. Research Project Goal: The proposed study would determine the impact of HIV on aging process, through a proxy association with risks of cardiovascular (symptoms screening, blood pressure measurement) and associated metabolic disorders (screening for diabetes mellitus and hyperlipidemia) among young adults PHIV and those uninfected. It aligns with the goal of the supplement and act on the overwhelming consensus and recommendations from literature, to further studies on comorbidities with NCDs and its role on aging among PLWH. The findings will broaden our understanding and enable prioritization of preventive, diagnostic and therapeutic strategies to avert early onset of NCDs and subsequent complications that may occur. 1.3. Aims of Research Training: The proposed research would assess the relationship of HIV infection and early onset of HTN and metabolic disorders, as well as initiate capacity to undertake research on HIV and aging through the following specific aims: Aim 1: To determine the prevalence of HTN and associated metabolic disorders among young adults PHIV compared to HEU and HUU. Hypothesis: We postulate a high burden of HTN and associated metabolic NCDs among PLWH due to lack of an integrated screening in the care continuum. Primary outcome: Determine the prevalence of HTN and associated NCDs among PHIV, HEU and HUU. Secondary outcome: Linkage rate among those identified and referred for specialized management of HTN and associated NCDs. Aim 2: To improve early detection of hypertension and associated NCDs among AYALWH, and linkage to care for appropriate management and care Linked to the above aims is an outcome that increases the capacity to conduct research on HIV and aging in Nigeria, through support and continuous mentorship. 1.4. Preliminary Data: The proposed study will be conducted within the context of PEPFAR- funded program, Action to Sustain Precision and Integrated HIV Response towards Epidemic Control (ASPIRE) - NU2GGH002417-01), implemented by IHVN, an indigenous Nigerian research, training and clinical care organization. Since it’s inception in 2004, 15,980,496 were counselled and tested for HIV (491,972 from October 2022), including 1,030,138 orphans and vulnerable children (OVC; 131,507 from October 2022), and 3,827,960 pregnant women (122,954 from October 2022). A total of 678,845 HIV positives were identified (17,408 pediatric and adolescents from October 2018), including 27,130 pregnant women (from October 2018), and initiated 381,952 individuals on ART including 16,244 pediatric and adolescents (from October 2018) and 103,630 pregnant women (26,538 from October 2018). The Operation triple zero (OTZ), a strategy focused to achieve optimal drug pick-up, ART adherence and viral suppression among adolescents and young adults across 383 treatment centers in three states and Federal Capital Territory (FCT) provide a base to identify and enroll individuals for the study. The project currently has a cumulative enrolment of 11,317 individuals out of which more than 7,127 fall within the target age group. Table 1. Adolescents and Young adults enrolment of Operation Triple Zero (OTZ) Operation Triple Zero Enrolments (Years) Years FCT Nassarawa 10.0- 14 15-19 20-24 10.0- 14 15-19 20-24 2020 131 178 96 26 36 23 2021 125 116 109 310 267 785 2022 382 983 2978 428 530 2026 2023 70 141 295 217 250 815 TOTAL 708 1418 3478 981 1083 3649 11317 2. Significance 2.1. There is increasing number of adolescents and young adults living with HIV in the population. The wider availability of combination antiretroviral therapy (cART) worldwide means the population of PLWH now lives longer. The burden of HIV is known already, but it is also important to establish the scale of associated comorbidities among the different population strata. A life-course approach to HIV management ensures availability of appropriate services from birth to old age through the continuum of prevention, care and treatment for those at risk, or already infected. One of the important issues to consider is the impact of comorbid neuropsychiatric and medical conditions over the life span, which may substantially overlap and interact with aging and antiretroviral drug toxicity.7 It is recommended that research on HIV/AIDS and aging should distinguish between at least two populations who may differ in important ways.7 2.2. HIV infection accelerates the aging process. Comparison of epigenetic age acceleration between blood of PHIV and HIV-uninfected adolescents indicates acceleration in blood of PHIV and poor cognitive functioning.8 Also, accelerated aging in PHIV shows hastened aging process and associated clinical manifestations.9 When followed longitudinally, HIV-infected adults compared with age and time interval-matched HIV-uninfected controls showed an early and substantial impact of HIV infection on aging process.10 2.3. There is growing evidence of HTN and associated comorbidities, and aging among PLWH including PHIV. Several evidence reported elevated rates of inflammation with associated higher risk of cardiovascular, renal and other diseases among PLWH, even when viral suppression is achieved and CD4 counts preserved.11Earlier findings in children with HIV (CWHIV) suggests ART-related lipodystrophy, dyslipidemia, and glucose intolerance, which predispose to early cardiovascular diseases.12Associated risk factors for HTN in adults aged 18-35 years with PHIV infection indicates no significant differences in the odds of most traditional or HIV-associated risk factors between those with HTN and those without.13Adults PHIV also have higher risk of non-AIDS diseases including HTN when compared with non- perinatally acquired HIV (NPHIV) and HIV-uninfected patients matched for age and sex.14 Findings from electrocardiography (ECG) and echocardiography (EC) in Uganda reported high prevalence of cardiac dysfunction among HIV-infected children on combination ART.15 Similar findings among CWHIV in Cameroun and Zimbabwe reported high burden of cardiovascular abnormalities.16,17 Also, NCDs are phenotypically characterized by accelerated aging from damaged DNA, telomere shortening and irreversible oxidative damage.18Previous studies have shown that HIV infection and use of ART can potentiate early onset of geriatric syndrome.19, 20 2.4. There is paucity of research and/or data on the risk associated with duration of HIV infection in Nigeria. Nigeria has the second highest number of children and adolescents infected with HIV globally, but studies on HIV-associated NCDs are limited. Findings from ALHIV in Lagos indicates dyslipidemia, low HDL and hypertriglyceridemia, which are known to be associated with cardiovascular and metabolic abnormalities.21Another finding among older PLWH in Akwa Ibom reported a 24.9% prevalence of HTN. A systematic review HIV, aging and NCDs that included studies conducted globally shows that only 2 studies were conducted in SSA among studies found to be eligible for inclusion.22 This may be due to inadequate research funding and HIV research capacity to answer relevant research questions in this setting,23even though the region accounts for more than two-thirds of people living with HIV globally.24 Research in this area will add to the scant knowledge and further our understanding to prioritize preventive, diagnostic and therapeutic strategies to minimize the long-term complications and improve the quality of life. 2.5. Innovation. The addition of comparison groups and inclusion of PHIV, especially those uninfected would be novel in the Nigerian setting and adds to the body of knowledge on the relationship of HIV and aging. 3. Research Design and Methods 3.1. Research Training Plan. The implementation of the research project will be overseen by Dr. Ahmad Aliyu, the immediate past Director of M&E, and presently Senior Technical Advisor at IHVN. In the current project, Dr. Aliyu is responsible for developing the research proposal to be implemented. He will obtain ethics approvals and oversee the hiring of staff and implementing the project, including review of data to ensure it is clean. He will oversee data analysis and write results of the research. He will be mentored by Drs. Kristen Stafford and Patrick Dakum, both Associate Professors at UMB-SOM. Dr. Stafford research interest focus on ongoing questions related to aging and non-communicable diseases in patients with HIV in sub-Saharan Africa, specifically evaluating the mechanisms of accelerated aging in people with HIV13,14 Also a faculty, Dr. Dakum is a public health physician whose research interest is on gerontology and HIV, including TB/HIV is based in Nigeria where he spends over 90% of his time. He leads IHV-Nigeria since inception in 2004 and has in-depth knowledge and expertise on HIV program administration and implementation, knowledge transfer and health advocacy to address human resource and health system gaps for improved HIV service delivery. He has mentored students and professionals in public health and health leadership in Nigeria for over 20 years. Their mentorship on skills for study design, data collection, data management, data analysis and dissemination of results, will benefit Dr. Aliyu in this and future projects. With support from the EXPAND supplement and guidance by the two mentors, the capacity of Dr Aliyu will be developed to initiate and lead research on HIV and Aging in Nigeria. A training to support early investigators to develop interest that will lead to the acquire knowledge and competences to conduct research on HIV and aging is within the scope of this supplement grant. We are proposing Dr. Aliyu to attend the next cycle of Sustained Training in Aging and HIV Research (STAHR). STAHR is a National Institute of Mental Health (NIMH)- funded collaborative state-of-the-art research training program that targets post-doctoral/early investigators and junior faculties with interest in gaining research expertise in either HIV or aging, or the intersections between the two. It is built on the infrastructure and expertise available at the University of California, San Diego – the Stein Institute for Research on Aging and the HIV Neurobehavioral Research Program. The training helps transform promising early investigators into high-quality independently funded researchers, with knowledge and skills to develop, implement and disseminate HIV and aging health research and make lasting contributions in that field. Apart from a core competency on research capacity, the program has additional mentoring network that includes scientists currently conducting research at the intersection of HIV/Aging. 3.2. Operational Definitions. Metabolic disorders: A cluster of five metabolic factors that include abdominal obesity, high blood pressure, impaired fasting glucose, high triglyceride levels, and low HDL cholesterol levels. Hypertension: is defined as measurements of two systolic blood pressure ≥140 mm Hg or diastolic ≥90 mmHg at least 3 months apart and/or prescription for an antihypertensive medication. Under this project, abnormal BMI, HTN, HBA1c, high triglycerides and low high-density lipoproteins (HDL) cholesterol will be used. 3.3. Study Design. This is a cross-sectional study of HEI, HEU and HUU 3.4. Study Location. The proposed study will take place at the following selected PEPFAR- supported health facilities implementing OTZ project in Federal Capital Territory (FCT) and Nassarawa state: 1) National Hospital Abuja (NHA), 2) Asokoro District Hospital (ADH), 3) Federal Medical Center (FMC) Jabi, 4) Dalhatu Arab Specialist Hospital (DASH), and FMC Keffi. 3.5. Study Period. The study will take place between October 1, 2023 and September 30, 2024 3.6. Study Population. Young adults aged 18-24 years with ability to give informed consent will be eligible for the study. Participants will be categorized in to three groups as follows: 1) PHIV recruited from the OTZ program; 2) HEU, recruited through mentor-mothers, a network of supports group of HIV-infected women who received prevention of mother-to-child transmission of HIV services and providing mentorship to prevent vertical transmission of HIV; 3) HUU to be recruited from the general out-patient clinic of the health facilities. Assuming a prevalence of 23%, 10% and 8%, and a margin of error of 7%, 5% and 4% among PHIV, HEU and HUU respectively, 455 participants will be recruited. Assuming an attrition rate of 10%, a sample size of 506 is sufficient. 3.7. Public Health Impact. Data and results from this project will be used to inform review of clinical care guidelines to routinize screening for cardiovascular and associated metabolic disorders in care of HIV/AIDS patients especially of Young Adults. 4. Human Subjects. The research protocol developed for this proposal will be reviewed by the National Health Research Ethics Committee (NHREC) of Nigeria (FWA# 00011634), and relevant Institutional Review Boards (IRB) of the health facilities. The protocol will be thoroughly peer-reviewed for human subject involvement and protection. All study staff will take the Collaborative Institutional Training Initiative (CITI) for certification and cleared by IHVN Research Compliance Office.